University of Pittsburgh Training Program in Antimicrobial Resistance

SUMMARY
Antimicrobial resistance is one of the most pressing public health issues facing the world today. However, a
paucity of local and national training opportunities dedicated to this field creates a critical gap that may impact
our current and future ability to tackle antimicrobial resistance. Accordingly, we propose to establish the
University of Pittsburgh Training Program in Antimicrobial Resistance (Pitt TPAR), which will train both
graduate students and post-doctoral fellows in advanced studies of antimicrobial resistance. Key attributes of
our exciting new program include the unparalleled resources and institutional support at the University of
Pittsburgh, and the multidisciplinary focus, commitment, experience and funding of our training faculty. Our
philosophy is that trainees should receive training that exposes them to a broad spectrum of advanced, cutting
edge, and novel approaches used in antimicrobial research to best prepare them to become creative and
independent investigators. Therefore, the overall objective of the Pitt TPAR is to provide a collaborative,
interdisciplinary, and coordinated team-mentoring effort to trainees from diverse academic backgrounds to
foster highly-skilled, independent investigators who have the technical, intellectual and leadership skills that will
allow them to make major contributions to the antimicrobial resistance field. This will be accomplished through
a co-mentorship structure, with one mentor being a strong content expert in the proposed area of research,
with the other(s) to be drawn from a range of disciplines as determined by the area of study. The expertise of
our mentors covers fields that are crucial for the comprehensive study of antimicrobial resistance, including i)
pathogenesis and molecular mechanisms of resistance, (ii) microbial genomics (iii) the human microbiome, (iv)
bioinformatics, (v) epidemiology and biostatistics, and (vi) infectious diseases modeling and simulation. We
have designed a unique educational curriculum that will provide core training in antimicrobial resistance, and
we will also nurture our trainee's oral and written presentation skills, and help them to establish a scientific
network that will advance their career. Collectively, we believe that the Pitt TPAR is unique in that it will
leverage concepts in drug resistance from diverse bacterial, fungal and viral systems, with the goal of
educating trainees in fundamental concepts of resistance, and enable the utilization of common themes for
their research.

Public health relevance
NARRATIVE We propose to establish the University of Pittsburgh Training Program in Antimicrobial Resistance, a multidisciplinary training program for pre-doctoral and post-doctoral trainees. The program will focus on translational science with the goal of having our trainees transition to postdoctoral fellowships or independent research careers. We plan to use this T32 to produce the next generation of scientists with the training, creativity, and resources to be future leaders in the critical field of antimicrobial resistance.